CSRD Research Career Scientist Award Application

Dr. Strigo runs a cross-disciplinary program that bridges pain physiology, psychopathology, psychological and
brain trauma and neuroscience. Her overall program aims to understand individual differences in pain
processing and its relation to chronic pain, psychiatric disorders, and opioid addiction. By experimentally
perturbing physiological, emotional, and brain responses to pain, Dr. Strigo uncovers alterations in pain
processing in individuals with depressive and trauma disorders and traumatic brain injuries. This innovative
approach addresses the complexity of pain and comorbidities in Veterans, leading to the development of
unique neurobehavioral biomarkers for tailored non-opioid interventions. Ultimately, seeking to improve pain
therapies and outcomes for all Veterans. Dr. Strigo was the first to identify and show differences in
interoceptive processing in major depression. She is known for the term “emotional allodynia” -- a qualitatively
altered negative emotional response to normally non-aversive stimuli or pain affect without pain sensation. Dr.
Strigo also pioneered research on changes in brain response to pain in post-traumatic stress disorder through
avoidant mechanism and in traumatic brain injuries through aberrant endogenous pain modulation. Her current
CS R&D funded work aims to identify specific neural mechanisms for pain-PTSD co-morbidity, ultimately
leading to novel, evidence-based therapeutic approaches, thereby reducing suffering and morbidity and
decreasing treatment costs. Dr. Strigo’s aims to translate her research discoveries into effective and
personalized pain management for Veterans living with pain, a high priority for the VA and VA primary care
providers. Her current, CS R&D-funded randomized controlled trial will provide another non-opioid therapy
available to Veterans with chronic pain by showing efficacy of weighted Blankets (WB) on pain and sleep
symptoms in Veterans suffering from chronic pain. The proposed research findings will provide critical
evidence for effects on pain and sleep disturbance for this novel, accessible and fully remote intervention.
Furthermore, Dr. Strigo established and provides research infrastructure for the Intensive Pain Rehabilitation
Program at SFVA. This endeavor resulted in cross-VA collaboration with five similar pain rehabilitation
programs across four different VAs across the country. Additionally, her research in pain management and
rehabilitation focuses on identifying unique clusters and phenotypes within chronic pain and predicting
treatment response, as well as factors driving opioid use/misuse in Veterans with chronic pain. This innovative
work using machine learning has begun to identify robust subgroups of patients and determine unique features
that predict their treatment trajectories. This will enable the assignment of individuals to the most effective
treatment options, promoting precision pain rehabilitation for Veterans with chronic pain, and improving their
overall well-being and functioning. This work is pivotal in understanding the effects of intensive pain
rehabilitation programs on Veterans and non-Veterans with chronic pain.

Public health relevance
Dr. Strigo’s research on pain neurobiology and its links to PTSD, TBI, and other co-morbidities is crucial for VA healthcare. It addresses the critical issue of pain-PTSD and related comorbidities, which significantly impact Veterans' health and healthcare costs. By identifying specific neural mechanisms, her work will lead to novel therapeutic approaches, reducing suffering and morbidity and decreasing treatment costs. Additionally, her research on non-opioid pain management and machine learning will advance precision pain rehabilitation, improving overall well-being and functioning for Veterans with chronic pain.